Mechanisms and Therapeutic Targeting of T cell Regulation in Heart Allograft Recipient Monkeys

Abstract
Heart transplantation (Tx) remains the therapy of choice for patients with end-stage heart failure. However, long-
term graft and patient survival remains suboptimal due to chronic rejection and high rates of morbidity and
mortality associated with life-long immunosuppression (IS). IS-resistant memory T cells (Tmem) play a major
role in chronic rejection and are considered a major barrier to graft survival. To date, no immunotherapy has
been clinically proven to be effective in the prevention or treatment of Tmem-mediated rejection.
Post-Tx inflammatory milieux promote cytokine-mediated pathogenic donor-reactive Tmem (darTmem) function
and are equally detrimental to donor-reactive regulatory T cells (darTreg). Reactive oxygen species (ROS)
promote interleukin (IL)-6 mediated graft injury and dysfunction. Concomitantly, IL-6 prevents T cell regulation,
promotes IS-resistant T cells, and abrogates long-term graft acceptance. Our preliminary data suggest that ROS
and IL-6 promote graft endothelial cell dysfunction in recipient monkeys. It is known that IL-7 and IL-15 jointly
orchestrate Tmem generation and persistence. IL-7 prevents T cell regulation, while IL-15 augments clonal
expansion of IS-resistant darTmem. Our preliminary studies demonstrate increased IL-7 and IL-15 mediated
pathogenic darTmem percentages and function at the time of rejection in recipient monkeys. Adoptive Treg
therapy remains at the forefront of innovative cell-based therapy in Tx. Treg engineered with chimeric antigen
receptors (CARTreg) that recognize specific donor MHC molecules home and reside in target tissues of
humanized mouse models, with superior suppressive function compared to conventional Treg.
In this application, we propose to test the unifying hypothesis that early post-Tx cytokine modulation and donor-
specific T cell regulation will induce durable high darTreg-to-darTmem ratios, promote long-term graft
protection, and maintain protective immunity. We propose to test this hypothesis, through combined (i) cytokine
modulation using newly developed rhesus-specific (rh) mAbs and (ii) administration of novel monkey Bw6-
specific CARTreg, in heart allograft recipient monkeys. We have 3 specific aims:
Aim 1: To investigate the impact of IL-6 neutralization on early post-Tx ROS-mediated graft injury and darTmem
development, using rh anti-IL-6 neutralizing mAb. Aim 2: To Attenuate the persistence of IS-resistant darTmem
through dual targeting of IL-7 and IL15 receptors in allograft recipients, using rh blocking mAbs. Aim 3: To induce
durable T cell regulation through combined administration of Bw6-specific CARTreg and cytokine modulation
conducive of prolonged graft acceptance.
The proposed research will define inciting molecular and cellular mechanisms that promote IS-resistant rejection
and provide the foundation for the development of novel and clinically relevant therapeutic strategies amenable
to rapid clinical translation.

Public health relevance
PROJECT NARRATIVE Long-term survival of transplanted heart grafts without the need for chronic use of immunosuppression will provide a better quality of life for organ transplant recipients. The proposed studies will explore innovative ways to achieve immunosuppressive drug-free long-term patient survival after heart transplantation.